Administrative and Research Translation Core (ARTC)

Abstract
The Duke University Superfund Research Center (DUSRC) aims to understand and address major public health
problems related to early-life co-exposure to hazardous contaminants and neurodevelopmental outcomes. The
Administrative and Research Translation Core (ARTC) of the DUSRC will provide holistic support of the
organized whole and promote integration of the constituent parts. The ARTC will be the formal and central
framework for support, oversight, and planning for the DUSRC’s research, events and activities. As such, the
ARTC will: facilitate central planning and coordination; provide fiscal oversight and guidance to ensure
compliance with institutional and federal regulations; leverage our stakeholder and partnership networks to
engage key stakeholders beyond the DUSRC; communicate needs-driven research and facilitate effective
research application; facilitate and promote the transfer of technology from Center Investigators to relevant
audiences; and build Center investigator and trainee capacity for timely and effective science communication
and research translation. The ARTC will employ a matrix structure for assimilation of this information and the
dissemination of research findings among Center Investigators, students, researchers and staff via monthly
Center-wide research discussion meetings, trainee chalk talks, weekly seminars and bi-annual symposia, annual
External Advisory Committee meeting, and consistent biweekly internal meetings of the ARTC PIs and staff. The
organizational plan of the Center consists of direct reporting lines from Project and Core PIs to the Center’s
Director, Dr. Heather Stapleton, and Deputy Director, Dr. Richard Di Giulio, and research translation efforts will
be supervised by Dr. Charlotte Clark. Through evaluation of annual milestones and success metrics, ARTC
management of the DUSRC will support a seamless systems approach to research with discovery across
projects and cores tightly coupled to accelerate progress; bidirectional communication with stakeholders;
avoidance of overdrafts and carry-overs on a regular basis; timely SRP data updates; timely NIH CareerTrac
database updates; timely online resource updates and production of translational material in support of
stakeholders and end users; and finally, trainees who receive high-impact, interdisciplinary environmental health
workforce training.

Public health relevance
Project Narrative The Administrative and Research Translation Core (ARTC) of the Duke University Superfund Research Center (DUSRC) provides holistic support to the Center’s five research projects and four cores. Through efficient central planning and coordination, fiscal oversight, stakeholder and partnership engagement, effective communication and trainee support, the ARTC will enable an integrated and efficient systems approach to research, and successful research translation. Annual milestones and measurement of success metrics will enable the ARTC to refine and adapt its approach to Center management, ensuring DUSRC objectives are met.